Identifying and Targeting Autoantigen Specific B cells in ANCA Vasculitis

PROJECT SUMMARY
I am an Assistant Professor at the University of North Carolina-Chapel Hill (UNC) School of Medicine and part
of the UNC Kidney Center. I am a clinician and researcher taking care of patients with autoimmune kidney
diseases with a specific interest in antineutrophil cytoplasmic autoantibody (ANCA) vasculitis. The current
treatment paradigm for ANCA vasculitis includes prolonged courses of immunosuppression. This approach is
effective but is associated with long term complications such as infections and malignancy. There is an
established cohort of patients with ANCA vasculitis enrolled in our registry. A subset of patients discontinue
therapy and remain off treatment without relapse, termed Long-Term Remission Off Therapy (LTROT). These
patients have been off therapy for at least 12 months and we have shown return of B cells. However little is
understood about the autoantigen specific B cells in long term remission off therapy or differences in BCRs which
indicate tolerogenic vs. pathogenic clonal populations. The first research aim is to define immunological
remission in terms of the underlying BCRs and the immunophenotype of autoantigen specific B cells in the
context of total B cell population. My goal is to identify markers of long-term immunological remission which can
be validated in future studies as a clinical tool. The second research aim is to develop therapies to remove
autoantigen specific B cells as a proof of concept study for future pre-clinical studies. My central goal is to build
innovative clinical tools which can minimize immunosuppression for patients with ANCA vasculitis.
I have developed a comprehensive career development plan integrating mentoring and training activities with
basic and translational research. My mentorship team includes Dr. Ronald Falk, a world-renowned physician-
scientist expert in ANCA vasculitis and co-mentor Dr. Benjamin Vincent, who will mentor me in translational
immunogenetics training. My advisory team includes an ANCA B cell expert and a nanoparticle formulation
advisor. I will train to develop nanoparticles as a selective therapy for autoantigen specific B cells. My training
will focus on lab-based research training supplemented by formal training activities including coursework,
national workshops, participation in national and international meetings, as well as instruction in scientific
communication and academic leadership. The focus of my training is on immunology, immunogenetics, and
nanoparticle drug development. My research aims and career development are supported by a world-class
environment at UNC which offers ample resources for junior faculty, including an established vasculitis clinic with
dedicated research coordinators for patient recruitment. My translational aims are to define long term remission
in the context of B cells and develop targeted nanoparticle therapy for ANCA vasculitis. My proposed K08
research aims, mentorship team, career development plan, and collaborative research environment will catalyze
my scientific productivity and provide me with the necessary training to become an independent investigator.

Public health relevance
PROJECT NARRATIVE In the short term, the proposed project will result in fundamental tools to identify immunological remission in ANCA vasculitis and development of novel nanoparticles which directly deliver therapy to cells which produce disease causing autoantibodies. In the long term, knowledge can be applied to other autoimmune diseases to develop similar approaches to minimize broad immunosuppression.